Utilizing Technology and AI Approaches to Facilitate Independence and Resilience in Older Adults

Abstract
Develop a build a robust AI-based dialog management system, a dialog model to guide and interact with
people living with Dementia in an autonomous, game-based, virtual world. The dialog model will be
driven by the integration of four input sources: facial and vocal emotion recognition, word spotting, and
historical usage and response data from previous virtual world experiences.

Public health relevance
Public Health Relevance Statement The virtual world, DevaWorld, shows efficacy in supporting the wellbeing of people living with dementia (“PLwD”) by delivering therapies and activities of daily living ("ADL") engagement through a dementia friendly interface. Today caregivers must spend extra time, effort, and have special skills to deliver results. With the autonomous play version enabled by this project, 1. DevaWorld’s behavioral therapeutic activities can be engaged without the need for interactive caregiver involvement. 2. PLwD can be primed for a higher completion rate of the ADLs that drive good management of chronic comorbidities and drive down healthcare costs. This also frees caregivers to focus on their care process and workflows, while DevaWorld digitally addresses disruptive behaviors and prepares PLwD for successful ADL completions.